Mechanisms of Asymmetric Cell Division in Developmental Hematopoiesis

Project Summary/Abstract
All blood cell types are derived from a single hematopoietic stem cell (HSC) precursor. HSCs must
balance expansion through self-renewing symmetric cell division with differentiation of progeny cells through
asymmetric cell division (ACD) to produce a functional blood system. When ACD is disrupted, profound blood
disorders occur often characterized by disproportionate production of specific blood cell types or uncontrolled
expansion of blood progenitors. The goal of the proposed project is to understand how ACD influences
developmental hematopoiesis and blood cell fate choice. Aim 1 will characterize how ACD occurs by
identifying molecular players using RNAi-based depletion in hematopoietic progenitors and
immunofluorescence techniques. Aim 2 will determine how ACD influences lineage choice during homeostasis
and stress by monitoring blood cell fate upon disruption of ACD during homeostasis and after stressors such
as oxygen deprivation or injury. Ultimately, these experiments will help elucidate a spatial and mechanistic
model for ACD in hematopoiesis while establishing a Drosophila model that will help accelerate advancements
in mammalian ACD hematopoiesis work.
My career goal is to become a successful independent researcher at a top-tier academic institution. I
aim to lead a research program that investigates how extrinsic cues from the niche and microenvironment
influence cell polarity and cell division to impact HSC self-renewal and blood cell lineage choice. To achieve
these goals, I will utilize techniques and training in basic cell biology and cytoskeleton research combined with
genetic dissection of hematopoiesis and advanced imaging techniques. I will pursue the proposed training
under the mentorship of Dr. Utpal Banerjee who has extensive experience using genetic techniques to dissect
the molecular underpinnings of hematopoiesis using Drosophila as a model system. Additionally, my advisory
committee will provide key support and resources to help me translate my findings to mammalian systems and
develop cutting edge imaging techniques to monitor the blood system in real-time during homeostasis and
stress. I will present my work and disseminate my findings at national and international conferences to help
advance my research, build collaborations, and establish myself in the hematopoiesis field. This project will
facilitate my transition to an independent research position by helping me establish the feasibility of using
Drosophila to study ACD during hematopoiesis and a foundation of preliminary work to build upon. UCLA is an
excellent place to pursue this work as it provides a rich landscape of resources, research collaborations, and
professional development opportunities to help me advance my career. As a junior faculty, I will take part in
training activities focused on leadership skills, grant writing, publishing in high impact journals, laboratory
management, and mentoring to help me develop the skills needed to run a successful research team.

Public health relevance
Project Narrative This proposal seeks to elucidate the cellular and molecular mechanisms that control the balance between self-renewal of blood progenitors and differentiation of mature blood cell types. Understanding how this balance is established during normal development and maintained during stress is relevant to blood disorders characterized by the production of disproportionate blood cell types such as fatal myeloproliferative disorder, anemia, and immune dysfunction upon aging. This work will help establish a model system that will allow for real-time monitoring of the blood system and ultimately the identification of key factors that regulate cell division and cell fate during hematopoiesis.